Bacterial Reprogramming that Contributes to Antibiotic Persistence toward Topoisomerase Inhibitors

ABSTRACT
Antibiotic treatment failure is one of the greatest global public health challenges of our generation. Antimicrobial-
resistant bacteria directly account for over 1.2 million deaths annually worldwide. Microorganisms that are
refractory to a new antibiotic often emerge shortly after the drug is introduced in the clinic. Besides becoming
heritably resistant to antibiotics, some bacteria in clonal cultures—coined persisters—can reversibly reprogram
their phenotypes and become transiently tolerant to a given drug. This can lead to infection relapse after a course
of antibiotics, rendering the treatment ineffective. Evidence further suggests that persisters have a higher
likelihood of acquiring resistance-conferring mutations. As such, the development of anti-persistence/resistance
therapeutic strategies can increase the success of antimicrobial therapy.
In this proposal, we focus on antibiotic persistence and resistance development in Escherichia coli and
Pseudomonas aeruginosa cells in slow/non-growing cultures, which are less responsive to antibiotics and more
difficult to eradicate than their growing counterparts. We aim to discover strategies to potentiate the activity of
existing and new topoisomerase inhibitors against these gram-negative pathogens. We recently found that
metabolic stimulation and loss of efflux pump action during topoisomerase inhibitor treatment reduce persistence
and resistance in non-growing E. coli. To build upon these findings, we will execute the following aims:
Aim 1: Discover metabolites that are abundant at infection sites that can modulate persistence and resistance
development of E. coli and P. aeruginosa toward first-in-class non-fluoroquinolone topoisomerase inhibitors that
are in clinical trials.
Aim 2: Investigate the impact of metabolic stimulation and loss of efflux pump action on bacterial metabolism,
DNA integrity, and viability during topoisomerase inhibitor treatment.
Aim 3: Deduce the effects of metabolic stimulation and loss of efflux pump action during topoisomerase inhibitor
treatment on the coordination of molecular events that are important for persister repair and resuscitation after
topoisomerase treatment terminates.
We envision that the successful completion of this project will expand our knowledge of persister survival
strategies and vulnerabilities. This will enable us to develop methods to enhance the activities of existing
antibiotics and preserve the efficacy of new drugs in development before their introduction to the clinic.

Public health relevance
PUBLIC HEALTH RELEVANCE New antibiotics that can act against gram-negative pathogens are limited and new therapeutic approaches are urgently needed. We aim to discover approaches to sensitize antibiotic-tolerant Escherichia coli and Pseudomonas aeruginosa to existing topoisomerase inhibitors along with compounds that are in clinical trials. We will investigate phenotypic changes that underlie bacterial survival in the presence of these drugs and as cells recover after antibiotic treatment terminates, which will enable us to develop strategies that thwart the evolution of antibiotic treatment failure and resistance development.